Research Training in Pediatric Allergy and Immunology

Project Summary
This application is a renewal of our longstanding training grant in Pediatric Allergy and Immunology. This
training program is designed to provide physicians and qualified Ph.D. candidates with the intellectual and
technical skills necessary to become successful physician scientists in the field of Allergy and Immunology. It
is fully expected that all trainees will go on to pursue full-time careers in academic medicine and the training is
specifically designed to accomplish that goal. Each trainee spends the vast majority of his/her time in direct
laboratory, clinical, and/or translational research, supplemented with formal course work and seminars, while
fulfilling required clinical training responsibilities. The Program Director actively oversees the training program
for each trainee and a single faculty member acts as the primary preceptor for each trainee, supervising
his/her research, helping to select those degrees and / or courses which will be most useful in the trainee’s
development, and insuring that the trainee’s other activities are appropriately limited so that success in
research training – the primary mission of the training program – is ensured. As will be detailed through this
application, the program has enjoyed great success in accomplishing its mission and is currently exceedingly
well positioned to continue at that same high level of achievement.
The 29 faculty included in this training grant include 18 professors and 5 associate professors. All
of the mentoring faculty are well funded, and most are exceedingly well funded. In addition to the seven core
faculty with primary appointments in our division, we have forged close relationships with other faculty from
across the Johns Hopkins community, 22 of whom are included in this application (16 professors and 4
associate professors). These include members of the divisions of Pulmonary Medicine in the Department of
Pediatrics, the divisions of Clinical Immunology, Infectious Diseases, and Pulmonary and Critical Care
Medicine in the Department of Medicine, the divisions of Environmental Health Sciences, Biostatistics, Child
Health and Development, and Epidemiology in the Johns Hopkins Bloomberg School of Public Health, and the
Institute of Genetic Medicine. Each of these faculty members is an active collaborator with one or more
members of our division’s faculty and each has actively participated in the training of our fellows and junior
faculty, demonstrating an enormous commitment to our training program and, most importantly, providing a
wide and dynamic range of research opportunities.
We are seeking funding for 3 trainees per year, with the intent being to enroll one new trainee per year
where M.D. candidates are accepted into a three-year, research intensive fellowship. However, we will also
leverage each funded position to maximize research time, so that some trainees will be funded by other
sources for any years with a heavier clinical focus, thereby freeing T32 resources to support other trainees with
protected research time.

Public health relevance
Project Narrative Allergic and immunologic disorders continue to rise in prevalence and currently account for many of the most common and important diseases affecting infants and children. The need for cutting edge basic, translational, and clinical research in pediatric allergy and immunology is therefore greater than ever, although exceedingly few programs are equipped to provide the training needed to conduct this research. Support for programs like ours, that are not only equipped to provide the best possible training but also have a documented record of success in producing the leaders in pediatric allergy and immunology, is therefore more important than ever.